Design and Feasibility of a Mobile Mental Health Stigma Reducing Intervention towards Optimization of Care for Black Adults with Depression and Anxiety

Project Summary/Abstract
This K23 proposal is designed to help Dr. Pederson achieve her long-term goal of becoming an independent
investigator with expertise in developing and testing interventions that reduce mental health stigma, increase
engagement in mental health services, and improve mental health outcomes. The candidate and her mentors
have developed a comprehensive training plan: 1) to build her expertise in user-centered design and digital
mental health intervention development, so that she can engage end-users early in the intervention design
process both in this study and in future trials; 2) to expand her training in community engaged research to
address health disparities and promote engagement in mental health services; and 3) to bolster her skills in the
conduct of clinical trials and quantitative analysis of clinical trial data for a future R01 application centered on
implementing and testing a fully powered anti-stigma contact intervention. The efficacy and precision of anti-
stigma interventions to improve mental health outcomes among underserved Black adults are grossly limited
and represent a critical public health gap. Studies show stigma compounds disabilities related to the primary
symptoms of mental illness, and increases morbidity and premature mortality related to mental illness.
Compared with white adults, Black adults with mental illness have more chronic disease, and more severe
illness at presentation. Meta-analyses have consistently shown that both face-to-face and video based contact
with individuals with mental illness can reduce stigma. Recent studies that distinguished contact delivery
showed effect size for video-based contact to be comparable to face-to-face contact. Digital mental health also
offers a platform to overcome barriers to early access, implementation, and scalability. Strong preliminary data
identify mental illness stigma and medical mistrust as critical intervention targets that should be addressed in
order to increase mental health service utilization among Black adults. To address these gaps in the literature,
the following specific aims are proposed: 1) a user-centered design approach will be used to develop a self-
administered, video-based mobile app to reduce stigma and medical mistrust among Black adults; 2) a pilot
randomized trial design will be used to assess the feasibility and acceptability, and test the preliminary efficacy,
of a self-administered, video-based mobile app in reducing mental illness stigma among Black adults with
moderate to severe depression or anxiety; and 3) a causal mediation analysis will be used to estimate the
extent to which changes in anticipated/enacted/internalized stigma and medical mistrust mediate the
intervention’s effect on the primary and secondary outcomes. The key innovation of this proposal is that it will
be the first mobile health intervention focused on mental health stigma reduction using a targeted approach by
integrating user characteristics (such as race, ethnicity and religiosity), while addressing medical mistrust using
a robust user-centered design approach and targeting service utilization.

Public health relevance
Project narrative The proposed research is relevant to public health because it is aimed at addressing low utilization of mental health services that leads to delayed diagnosis and treatment, and increased morbidity and mortality related to mental illness among Black adults. The proposed research is relevant to the mission of the NIMH to enhance the efficacy and precision of interventions, as it is proposed to design and test the feasibility of an anti-stigma intervention that better defines the optimal intervention conditions and mechanistic targets (stigma and medical mistrust) to promote uptake of mental health services. Thus, the findings are expected to enhance mental health treatment outcomes among millions of Black adults with mental illness in the United States.